Vascular MicroRNA-212 in CAA and Alzheimer's disease

Summary
Pathological changes in the brain vasculature contribute to Alzheimer’s disease (AD) and AD-related dementias
(ADRD). Amyloid β (Aβ)-mediated endothelial damage may lead to microbleeds, stroke, hypoxia, alterations in
cerebral blood flow and malfunction of the entire neurovascular unit, contributing to cognitive impairment. Micro-
RNAs (miRNAs) regulate gene expression and protein levels, bearing functions essential for cell survival and
functioning in normal and stress conditions. MiRNAs are highly enriched in the brain and play critical roles in
development and disease. While the vascular contributions to AD pathology are well recognized, the changes in
miRNA expression in endothelial cells in the AD/ADRD brain are still mostly unexplored.
We propose to assess the effect of amyloid challenge on miRNA regulation in cerebral endothelial cells,
addressing the overarching hypothesis that the Aβ peptide, a known causative factor of AD, triggers endothelial
miRNA alterations, the most significant being miR-212 downregulation, contributing to the blood-brain barrier
(BBB) failure and neurovascular dysfunction characteristic of AD. Our specific goal is to demonstrate the
hypothesis that the Aβ peptide promotes cerebrovascular dysfunction and BBB failure via endothelial
miR-212.
Using human primary and immortalized endothelial cells, purified cerebral vessels from transgenic mice with
vascular amyloidosis, and post-mortem brain vasculature from human AD cases with vascular Aβ and pure
cerebral amyloid angiopathy (CAA) cases, we aim to test the following hypotheses that: Aim 1: toxic Aβ species
specifically reduce miR-212 in cerebral endothelial cells. Aim 2: MiR-212 targets modulate endothelial
cell stress/death genes and pathways. Aim 3: miR-212 loss disrupts BBB function.
This project will benefit from the combined expertise and collaboration of two PIs specialized respectively in
vascular/endothelial dysfunction in CAA and AD and miRNA research in AD and ADRD. This study will allow us
to clarify the role of specific vascular miRNAs and, by re-establishing their correct equilibrium, restore gene
expression and biological networks in the cerebral vasculature. The long-term goal of the proposed research will
be the development of novel miRNA-focused therapeutic strategies against neurovascular dysfunction in AD and
related dementias.

Public health relevance
The vascular contributions to cognitive impairment and dementia are well recognized mediators of Alzheimer's disease and related disorders, and endothelial cells are essential players in the vascular pathology due to their role of gatekeepers of the blood-brain barrier (BBB). Micro RNAs are short non-coding RNAs that regulate cell survival and function, but their role as contributors to endothelial cell stress and death mechanisms as well as BBB permeability in AD and cerebral vascular amyloidosis is largely unknown. Here, through the use of human endothelial cells in culture and vessels purified from mouse and human brains with vascular amyloid deposits, we plan to test the hypothesis that the miR-212 downregulation induced by Amyloid β contributes to BBB failure and neurovascular dysfunction in AD and related dementias.